Prenatal Exposures and Child Health Outcomes 2: A Statewide Study of Michigan Families

This project will be conducted by investigators from a coalition of Michigan institutions
that participated in ECHO Cycle 1. We began with two prospective observational cohort
studies—the Archive for Research on Child Health (ARCH) and the Michigan ARCH
(MARCH). Participants in the ARCH cohort were enrolled at first prenatal visit, largely in
Lansing, MI, between 2008 – 2016. In 2016, we expanded recruitment to create the
MARCH cohort, which is a stratified random sample of births in the lower peninsula of
MI. In MARCH, we aimed for a statewide sample of 1,000 births and then chose to enroll
an additional 100 births in Flint, MI. As of March of 2025, 1,150 participants joined
ECHO Cycle 2, including new pregnancies, with high follow-up rates (91% of core data
elements, 76% of all possible biospecimens). Our aims will contribute to ECHO science
by: Aim 1. Using core ECHO data, we will investigate the effects of a) micronutrient
levels in pregnancy; b) early infancy feeding patterns and the gut microbiome; and c)
early life adversity at multiple intersecting levels of maternal, family, and neighborhood
stressors, in relation to child health outcomes. Aim 2. We will study the effects of
mixtures of per- and polyfluoroalkyl substances (PFAS), phthalates and heavy metals in
pregnancy on child body mass index, metabolic function, and neurodevelopment,
examining the gut microbiome as a potential effect mediator/modifier. Aim 3. We will
follow the ECHO participants from our current cohorts, continue to reconsent our ARCH
and MARCH cohort participants into ECHO-2, and recruit additional pregnant women to
the ECHO cohort. We also aim to enroll approximately 225 mothers of the anticipated
450 live births for pre-conceptional data collection from whom we anticipate enrolling 67
subsequent children to produce a total study sample of approximately 2,200 Michigan
families. Aim 4. We will examine preconception exposures in men that accelerate sperm
epigenetic aging for their effects on offspring neurodevelopment and obesity and test the
hypothesis that we can identify a signature of the extracellular preconditioned secretome
in the circulating plasma of pre- conceptional women that is associated with an
increased risk of recurrent preterm birth. When we have completed our recruitment and
detailed assessments of pregnant women, their children, and conceiving partners where
feasible, we will be able to make a very substantial contribution to the overall goals of
the ECHO program

Public health relevance
Public Relevance Statement: Many important problems in child health and development may result from a mother’s environment during pregnancy. We are a coalition of scientists in Michigan who plan to 1) continue collecting information from the families we have already enrolled in the Environmental influences on Child Health Outcomes (ECHO) study; and 2) continue to enroll more families from Michigan. Working together with other study groups who are part of the national ECHO program, we hope to learn what changes might be made during a woman’s pregnancy that could prevent later problems in child health and development.